Nanoformulated CRISPR Ribonucleoproteins for Ultrasound-Facilitated Brain Gene Editing

Nanoformulated CRISPR Ribonucleoproteins for Ultrasound-facilitated Brain Gene Editing
Abstract
Emerging CRISPR technologies provide new opportunities to advance gene therapy in treating many
intractable genetic diseases, including neuronal degeneration disorders. Given the failures of clinical trials in
treating Alzheimer's disease through directly targeting amyloid β and tau, there is an unmet need to develop a
different strategy in this space, and gene editing technologies may be of great potential. However, one key barrier
in developing CRISPR therapeutics is the brain delivery of CRISPR components. Viral vectors could be effective,
but the use of these vectors could potentially raise the concerns in immunogenicity and toxicity, which may lead
to severe adverse effects. Conventional nonviral systems, in contrast, could be safer but significantly less
effective, possibly due to the suboptimal size, which limits their transport to the target brain region. In light of
these challenges, we propose to explore the feasibility of screening more transport-favorable, effective nonviral
carriers for brain gene editing to tackle Alzheimer's disease. Different from the conventional nanoparticle designs,
we will first create a large nanoformulated CRISPR/Cas9 ribonucleoprotein library through split-and-pool lipid
coating and optimize the focused ultrasound (FUS)-mediated blood-brain barrier opening to screen all the
possible lipid compositions (Aim 1). Compared with the conventional nanoparticle formulations, direct lipid
coating may generate smaller and more transport-favorable “nano editors.” By barcoding each lipid in each split-
and-pool round, all the nanoformulated Cas9 ribonucleoproteins can be screened directly in the same animal,
which minimizes the variations from animals and operations. Our preliminary studies with a small set of
nanoformulations in different models have demonstrated the feasibility and reproducibility of our screening
approach. Once having the most potent lipid composition, we will validate its gene editing performance and
therapeutic efficacy in both reporter and Alzheimer’s mouse models (Aim 2). Our previous efforts in developing
FUS delivery for viral brain gene editing have helped us established the capability and all the pipelines needed
for editing performance validations. In this proposed research, we aim to expand the CRISPR delivery toolkits
from viral to nonviral systems and to explore the potential of nonviral CRISPR gene editing for treating
Alzheimer’s disease. The discoveries and findings will help us gain enough supports for larger, potentially IND-
enabling studies.

Public health relevance
Narrative Somatic gene editing in the brain may be amenable to the treatment of many neuronal degeneration disorders including Alzheimer’s disease; yet, delivery is a key hurdle hindering the development of CRISPR therapeutics for brain gene editing. Viral vectors could be effective but with the concerns of immunogenicity and toxicity, while conventional nonviral systems are inefficient in delivering CRISPR components, possibly due to the suboptimal size, which limits their transport to the brain. In light of these challenges, we propose to create a large nanoformulated CRISPR ribonucleoprotein library through split-and-pool lipid coating and to leverage the merits of focused ultrasound-mediated blood-brain barrier opening to find more transport-favorable, effective formulations for brain gene editing and potentially for treating Alzheimer’s disease.